Genomics

ABSTRACT – GENOMICS SHARED RESOURCE
The Genomics Shared Resource is managed by the Cancer Center and provides full nucleic acid-to-data
services, from library preparation to basic data analysis, focused primarily on next-generation sequencing (NGS)
applications. Most of the services currently offered by the Core have been added in the last 5 years following the
recruitment of Dr. Brian James as the Facility Director in 2013. The Core upgrades in the past funding period
include Illumina-based sequencing on the NextSeq 500, automated library preparation using the Eppendorf
epMotion 5075, single-cell sequencing on the 10x Genomics Chromium and Bio-Rad ddSeq platforms, and
human cell line authentication using the Promega GenePrint 10 system. In addition to RNA-seq, services offered
include ChIP-seq, ATAC-seq, single-cell RNA-seq, exome-seq, CRISPR libraries, and phage display libraries.
Since the Genomics Core began offering NGS service, it has worked with the majority of Cancer Center member
labs. In many cases, this was the lab's first experience with high-throughput sequencing technology, and the
Core was instrumental in helping the investigators to design, execute, and interpret these experiments.
Integrated basic NGS bioinformatic analysis is included as part of the service. This is a critical component in
assuring the quality of the data produced and facilitating the eventual scientific success of the Center members.
The Genomics Core provides broad support, with 41 Center labs having used the Core in the last 5 years, and
it has supported at least 46 cancer-related publications.